Optoretinography: All-optical measures of functional activity in the human retina

Project Summary/Abstract
The optoretinogram (ORG) holds great promise as a probe of cone function in normal eyes, in the assessment
of disease states of cones in disease, and in the evaluation of therapeutic interventions. To achieve its
promise, the cellular and molecular basis of the ORG needs to be established, and methods standardized for
application in the clinical setting. This supplement will pursue research opportunities that have opened up
under the current Bioengineering research partnership, but were previously unforeseen. These include the
addition of adaptive optics to rodent optoretinography in order to improve signal fidelity and resolution at
Stanford University. Second, in a collaborative effort between UC Davis and UW, a key discrepancy was
discovered previously in all extant measures of pigment bleaching; this supplement will aim to resolve this
issue and elucidate the mechanistic basis of the cone ORG. Lastly, the rapid development of a patient-friendly
variant of the ORG at UW has accelerated the recruitment of patients with inherited retinal disease, and
created an opportunity to standardize the ORG protocols for studying genotype-phenotype correlations in a
clinical setting. Support from the supplement will provide an avenue to explore these three unanticipated,
exciting and critical areas, thus providing synergy to the clinical, technological and mechanistic facets of the
project.

Public health relevance
Project Narrative This proposal outlines a plan to develop the technology for measuring the Optoretinogram, or ORG: the all- optical recording of functional activity of retinal neurons and their connections in a living eye. We employ a unique combination of technologies (OCT, adaptive optics, interferometry, eye-tracking) that together enable in vivo access to the early visual processing elements in the retina in humans. In the end, we envision powerful, clinically deployable tools suited to test and accelerate the new generation of treatments aimed at regenerating neurons and neural connections in the eye and visual system.